National Research Meeting on Medical and Social Care Integration

National Research Meeting on Medical and Social Care Integration Project Summary/Abstract Growing awareness of the health and health equity impacts of social and economic disadvantage, coupled with a shift towards value-based care, has resulted in a surge of interest in identifying and mitigating social risks to improve health, health equity, quality of care, and health care costs. As a result, providers in a wide range of settings along with both private and public payers are eager for evidence about effective interventions related to medical and social care integration. To help create a forum for research stakeholders in this field, in February 2019, we convened 150 researchers and implementers for a 1.5-day research meeting in Portland, Oregon that was partially supported by a previous AHRQ R13 grant. The high yield meeting contributed to new research collaborations and projects that continue to advance work in this area. Interest in evidence of the effectiveness and implementation of social interventions research has only grown since February 2019, as federal and state incentives are encouraging providers and payers to invest in social care interventions. The COVID-19 pandemic also has brought a unique urgency to articulating and bolstering the health sector's role in addressing social risks. More than ever, stakeholders investing in this area can benefit from reviewing the state of the rapidly evolving science and together defining a common agenda to advance this new field of health services research and practice. We believe that the time is right to build on the foundation created by the 2019 meeting to convene a second national research meeting (250-300 attendees) over two full days to showcase the latest research and stimulate discussion and increased collaboration across disciplines and sectors. We intend to include diverse voices and perspectives in meeting activities. As we did in 2019, we will provide travel grants to support participation from both patient experts with lived experience with social adversity and early career researchers from demographic groups that are under-represented in health services research. We also will engage in multiple dissemination activities to ensure meeting content is widely disseminated beyond the conference attendees. If the global context prohibits in-person convening, we will hold a hybrid in-person/virtual or fully virtual meeting. The meeting supports a core AHRQ research priority: harnessing data and technology to improve health care quality and patient outcomes and to provide a 360-degree view of the patient.

Public health relevance
National Research Meeting on Medical and Social Care Integration Project Narrative Building on the success of the first “State of the Science: A National Research Meeting on Medical and Social Care Integration” in 2019, we propose a second meeting in Fall 2021 focused on both assessing and accelerating research on health care-based social interventions that can reduce health inequities and improve population health, health care quality, and the experience of care. State of the Science 2021 will gather 250-300 researchers and research stakeholders from across the nation to identify key research gaps, discuss methodological issues, and develop new research collaborations. If the global context prohibits a large in- person convening, we will hold a hybrid in-person/virtual or fully virtual meeting.